Functional mapping of thirst circuits in the aging mouse brain

PROJECT SUMMARY/ ABSTRACT
Fluid homeostasis, the maintenance of volume and osmolality in blood and interstitial fluid, is essential for life.
Aging involves breakdown of fluid homeostasis, and is often accompanied by reduced thirst and drinking
behavior. As a result, dehydration is one of the major health risks in older individuals, exposing them to higher
risk for developing diabetes mellitus, heart or kidney failure, or reduced or loss of consciousness, and thereby
greatly increasing their mortality. However, the mechanism by which thirst and drinking behavior changes with
advancing age is very poorly understood. Fluid homeostasis is primarily regulated by a structure in
hypothalamus called the subfornical organ (SFO), which monitors the state of fluid balance via direct access to
systemic circulation. Recently, a specific population of neurons within the SFO was shown to be both
necessary and sufficient for regulating drinking behavior. Here I propose to systematically investigate how the
thirst circuit changes with aging, using fiber photometry and optogenetic techniques in awake behaving mice.
Understanding how the function of the thirst circuit changes with age will expand our ability to develop
interventions and treatment for fluid imbalance and related illnesses in the elderly.

Public health relevance
PROJECT NARRATIVE Dehydration and fluid imbalance is a major health risk for the elderly in the US and worldwide, but how the neural circuits that control thirst and fluid homeostasis change with age remains unknown. This project will address how thirst circuits in the hypothalamus decline during aging in a mouse model. Understanding how the function of the thirst circuit changes with age will expand our ability to develop interventions and treatments for fluid imbalance and related illnesses in the elderly population including cognitive decline, heart or kidney failure, diabetes mellitus, osteoporosis and fractures.